PRODUCING ARTEMISININ FROM A. ANNUA CELL CULTURES

Artemisinin, an anti-malarial drug isolated from the plant Artemisia annual, has undergone extensive testing by the US Armed Forces, AID, and the WHO because it is effective against strains of malaria which have become resistant to chloroquines, the traditional drugs of choice. Attempts to develop a protocol which can be used for commercial production of the drug have thus far failed because the plant produces artemisinin only in minute amounts (0.01-0.05%). Production of the compound through traditional tissue culture practices has not been promising. Synthesis of the drug is possible but has proven to be prohibitively expensive. To overcome these problems, we propose to increase in situ through leaf organ cultures the number of glandular trichome cells. These cells are thought to be directly involved in the biosynthesis of artemisinin. The trichome mother cells from which the gland cells arise will be natural targets for induction of cell division by plant hormones since the developmental program for these types of cells appears to be transmitted through cell lineage. Glandular trichomes can then be isolated from leaf organ cultures and grown in liquid batch culture where subsequent phase research can optimize artemisinin production in bioreactors or by cell culture immobilization techniques with the objective of proving commercial viability.